The DNA replication-repair interface: mechanisms and regulation

PROJECT SUMMARY
DNA replication in eukaryotes is carried out multiprotein complexes that carry out a variety of enzymatic activities
required for faithful genome duplication. Regulation and coordination of these activities at replication forks are
essential for genomic stability. The replisome regularly encounters impediments that stall the replication fork,
including DNA damage, aberrant DNA structures, and transcription conflicts. Stalled forks are a major source of
genomic instability and underlie diseases including cancer. Replication-repair pathways serve to stabilize, repair,
and restart stalled forks. However, the molecular mechanisms of these pathways are poorly understood. We are
addressing this gap in knowledge by determining structures and mapping interactions within and among
multiprotein-DNA complexes and combining this information with their biochemical and cellular functions. Our
long-term goal is to decipher the molecular mechanisms and regulation of replication-repair pathways to
understand how errors in these processes lead to disease. We are currently focused on three enzymatic activities
essential for faithful genome duplication—(1) initiation of DNA synthesis by DNA polymerase (pol) α–primase,
(2) fork reversal and template switching by ATP-dependent DNA translocases, and (3) DNA glycosylase
mediated repair of interstrand DNA crosslinks (ICLs). (1) Polα–primase is a core component of the eukaryotic
replisome that initiates DNA synthesis by generating chimeric RNA-DNA primers necessary for replicative
synthesis by polδ and polε. Despite the importance of this critical activity, how polα–primase primes synthesis in
the context of the replisome and how the primer is transferred to polδ for Okazaki fragment synthesis are
unknown. We are determining structures of polα–primase with nucleic acid substrates and protein partners at
various stages of its catalytic cycle and visualizing conformational states by electron microscopy and biophysical
approaches. (2) Fork reversal involves remodeling a stalled fork into four-way junctions to prevent fork collapse
and facilitate replication restart. Our work will address how HLTF, SMARCAL1, and FBH1 provide unique repair
activities at damaged forks, their mechanisms of fork reversal, and how the ubiquitin ligase activities of HLTF
and FBH1 regulate fork reversal. (3) Abasic (AP) sites are one of the most abundant forms of DNA damage and
react with the opposite strand to form an AP-ICL. The NEIL3 glycosylase unhooks AP-ICLs at convergent
replication forks by an unknown mechanism. Our previous work defined NEIL3’s specificity for AP-ICLs in a
particular arrangement and spacing from a fork junction, as well as the structure and DNA binding of the C-
terminal GRF zinc finger domain. We are working to understand how the unique architecture of NEIL3 enables
its recruitment and positioning at convergent forks, and how the catalytic domain is capable of accessing a
conformationally constrained crosslinked nucleotide. Our work addresses critical gaps in knowledge related to
how the intrinsic activities of these enzymes are regulated by interactions within the replisome.

Public health relevance
PROJECT NARRATIVE Errors in DNA replication caused by DNA damage lead to genomic instability and are associated with diseases including cancer. This proposal focuses on pathways that ensure proper replication and suppress mutations. Elucidating the molecular mechanisms of the proteins involved in these pathways will help to understand how cells maintain genomic integrity and have potential to generate new therapeutic strategies against replication associated diseases.